Molecular mechanisms of resistance to HER2 inhibitors in breast cancer

DESCRIPTION (provided by applicant): This proposal describes a five year training plan for the development of an independent translational academic cancer research program. The candidate has had research training as a graduate student and residency training in internal medicine, has completing fellowship training in hematology/oncology, and continues as faculty in a mentored research environment. The proposed program will promote the candidate's further training in advanced cancer biology, mouse models of cancer, and translational breast cancer research. The candidate's mentor is a recognized leader in breast cancer basic science and translational research, and is committed to supervising the PI's research training and fostering his transition to independence. Training will occur in an environment of active clinical practice and basic science investigation in breast cancer, coupled with outstanding resources for the proposed research and with institutional support for the nurturing and development of physician-scientists. The proposed research will focus on understanding molecular mechanisms of resistance to HER2 inhibitors in breast cancer. Amplification of the HER2 oncogene occurs in 25% of human breast cancers. Trastuzumab, an antibody against HER2, and lapatinib, a tyrosine kinase inhibitor of HER2 and EGFR, are effective therapies for patients with HER2+ breast cancer, but most patients treated with these agents eventually relapse, suggesting that tumors acquire or intrinsically possess mechanisms for escape from HER2 inhibition. Aberrant activation of the phosphoinositide-3-kinase (PI3K)-Akt axis is emerging as an important mechanism of resistance to anti-HER2 therapies, supported by preliminary data from cell line model systems of lapatinib resistance. We hypothesize that as a result of the selective pressure of treatment, resistance to HER2 inhibition results from reactivation of the PI3K-Akt axis through upregulation of alternate compensatory signaling and/or mutations in the PI3K pathway. Inhibition of these alternate pathways should provide therapeutic targets to prevent or overcome resistance to anti-HER2 treatment. Specific aims are 1) To determine the molecular mechanisms of aberrant PI3K-Akt activation in lapatinib-resistant HER2-overexpressing breast cancer cells; 2) To determine the mechanisms whereby PI3K mutations contribute to PI3K-Akt pathway activation in drug-resistant cells; and 3) To determine whether therapeutic inhibitors of PI3K restore sensitivity to HER2 inhibitors and whether PI3K pathway activation predicts clinical response to HER2 inhibitors. Experiments in Aim 1 will use cell line models of lapatinib resistance to determine the role of HER3 in activating PI3K, or to identify other candidate activators of the PI3K pathway. Several approaches including RNAi knockdown of candidate proteins, immunoprecipitation of PI3K subunits to identify binding partners, and pharmacologic manipulation of suspected resistance pathways will be tested. Aim 2 will focus on understanding the role of PI3K mutations by using mass spectrometry to quantitate mutant PI3K isoforms in resistant cells, and by knockdown of PI3K subunits to test the role of mutations on PI3K signaling. Using xenograft mouse models, Aim 3 will test whether PI3K mutations confer resistance in vivo, and whether combination of PI3K inhibition with HER2 inhbitors provides a strategy to overcome HER2 inhibitor resistance. Further, the hypothesis that activation of the PI3K pathway by PIK3CA mutation or PTEN loss predicts for clinical resistance to HER2 inhibitors will be tested in tumor samples from a neoajuvant clinical trial of lapatinib.

Public health relevance
PUBLIC HEALTH RELEVANCE: Treatment of HER2-positive breast cancer with targeted therapies has been successful, but despite the effectiveness of these therapies, most patients eventually progress after treatment. This research will focus on understanding how tumors develop resistance to HER2-directed therapies. This work will also test potential strategies for overcoming that resistance, to benefit public health by improving the outcome of patients with HER2-positive breast cancer. PUBLIC HEALTH RELEVANCE: Treatment of HER2-positive breast cancer with targeted therapies has been successful, but despite the effectiveness of these therapies, most patients eventually progress after treatment. This research will focus on understanding how tumors develop resistance to HER2-directed therapies. This work will also test potential strategies for overcoming that resistance, to benefit public health by improving the outcome of patients with HER2-positive breast cancer. __SpecificAimsTextDelimiter__ Approximately 25% of human breast cancers overexpress the HER2 receptor tyrosine kinase (RTK), a member of the ErbB receptor family. Amplification of HER2 confers a poor prognosis (Slamon 1987, Siamon 1989) but also renders these tumors susceptible to targeted therapies against HER2. There are two FDA approved therapies for metastatic HER2+ breast cancer, the monoclonal antibody trastuzumab, and the small molecule tyrosine kinase inhibitor lapatinib (Slamon 2001, Geyer 2006). Despite these advances, most patients with metastatic HER2+ breast cancer eventually relapse after treatment, suggesting that tumors acquire or intrinsically possess mechanisms for escape from HER2 inhibition. One of the most important effectors of HER2 signaling is the phosphoinositide-3 kinase (PI3K)-Akt axis. Inhibition of this signaling pathway has been shown to be required for the antitumor activity of HER2 inhibitors. Indeed, resistance to ErbB receptor inhibitors in breast and other cancers has been associated with continued activation of the PI3K pathway. Mutations in PIK3CA, the gene encoding the p11 Ou catalytic subunit of PI3K, are a frequent genetic alteration in human breast cancer, where they occur in about 25% of cases sometimes coexisting with HER2 gene amplification (Samuels 2004, Saal 2005). We hypothesize that as a result of the selective pressure of treatment, resistance to HER2 inhibition results from reactivation of the PI3K-Akt axis through upregulation of alternate compensatory signaling and/or mutations in the PI3K pathway. Inhibition of these alternate pathways should provide therapeutic targets to prevent or overcome resistance to anti-HER2 treatment. To test these hypotheses, we propose the following specific aims: Aim 1: To determine the molecular mechanisms of aberrant PI3K-Akt activation in lapatinib-resistant HER2-overexpressing breast cancer cells Aim 2: To determine the mechanisms whereby PI3K mutations contribute to PI3K-Akt pathway activation in drug-resistant cells Aim 3: To determine whether therapeutic inhibitors of PI3K restore sensitivity to HER2 inhibitors and I whether PI3K pathway activation predicts clinical response to HER2 inhibitors